Transition metal photosensitizers with metal-metal bonds

Project Summary/Abstract
Many of the efficient photosensitizers utilized today are monometallic and consist of noble metals, such as
ruthenium and iridium. These noble metal photosensitizers utilize high-energy radiation which leads to substrate
degradation & unwanted side products in organic synthesis. Low permeability of high-energy radiation also limits
photodynamic therapy applications only to the skin. These noble metals are also high in toxicity and create
adverse side effects. The proposed research focuses on achieving complementary photoreactivity using
inexpensive, environmentally benign and cheap earth-abundant metals by switching to a multimetallic paradigm.
The overall goal is to invent new photosensitizers using earth-abundant metals to complement traditional noble
metal reactivity and develop sustainable organic reactions and photodynamic therapies. Metal-metal bonding in
the proposed photosensitizers will also facilitate a red-shift in the operational wavelength eliminating all the
drawbacks of high-energy radiation in the above applications.
Upon successful completion, aim 1 will yield a novel class of multimetallic earth-abundant metal
photosensitizers which can perform photoredox catalysis. These photosensitizers will feature high excited state
lifetimes and perform organic transformations in target substrates identified utilizing their redox potentials.
Successful completion of aim 2 will yield a class of multimetallic carbon-monoxide-releasing-molecules that
feature metal-metal bonds which facilitate red-shifted absorptions and photo-dissociation of CO in wavelengths
in the therapeutic window laying out the groundwork for photodynamic therapies in internal tissues. This project
will also yield working predictive computational models for optimization of the photosensitizers.
The proposed research is significant because it applies an underdeveloped photosensitizer paradigm—
metal–metal cooperativity—to develop photosensitizers that overcome the limitations of traditional noble metal
monometallic photosensitizers in organic synthesis and photodynamic therapies. The proposed research will
also provide the intellectual foundation for potential long-term applications in LEDs and solar cells using earth-
abundant metal photosensitizers, thereby advancing knowledge across different fields. The rationale for pursing
the proposed studies is derived from the careful analysis of the independent literature on precious-metal
bimetallic photosensitizers, which show a relationship between the metal–metal cooperativity and
photosensitizer parameters, such as absorption intensity and wavelength. Preliminary experimental results in
our lab also support our hypothesis. All the resources and the expertise required to pursue the proposed research
are available at Saint Louis University or in nearby institutions with which the PI has already established relevant
connections.

Public health relevance
Project Narrative The goal of this proposal is to develop multimetallic photosensitizers with earth-abundant metals that utilize metal-metal cooperativity to complement the reactivity of noble metal photosensitizers. Proposed photosensitizers are useful in organic synthesis utilized for drug development and photodynamic therapies aimed at reducing illness.